Natural genomic variants that influence cryptococcal pathogenicity

PROJECT SUMMARY
Natural genomic variants that influence cryptococcal pathogenicity
Cryptococcus neoformans is a global pathogen responsible for hundreds of thousands of deaths yearly in HIV+
individuals and increasing morbidity in non-AIDS patient populations. C. neoformans strains collected from pa-
tients with cryptococcal meningitis have been used to elucidate C. neoformans evolution and in efforts to corre-
late disease outcome with in vitro measures such as virulence factor production or fungal growth. We know that
distinct genome sequences are associated with varied clinical outcomes. However, we do not know which natural
genomic variants are responsible for the differential virulence of clinical isolates.
Our long-term goal is to understand the molecular mechanisms by which natural variation in the cryptococcal
genome determines pathogenicity. A first step toward this goal is to identify naturally occurring variants that can
be experimentally proven to influence virulence, at single-gene resolution. The next step is to characterize the
impact of variants in these genes on cryptococcal biology and disease progression. We hypothesize that we can
combine genetic and genomic methods with experimental follow-up to identify, validate, and characterize natu-
rally occurring variants that significantly influence cryptococcal virulence. This hypothesis is supported by our
compelling preliminary data, in which two distinct genetic methods implicate variants in the same genomic region
as influencing infectivity.
We propose to achieve our goals by pursuing three Aims: Aim 1 is to use two distinct, complementary statistical
genetics methods to discover genomic regions containing naturally occurring variants that influence fungal viru-
lence. Aim 2 is to further apply genetics, supported by expression analysis and mutant studies, to refine these
regions and identify specific high-priority genes within them. Aim 3 is to use genome engineering to validate the
influence of selected variant genes on virulence and to assess their effects on fungal gene expression, physiol-
ogy, and pathogenicity in a mouse model.
Applying an unbiased strategy to identify genes harboring natural variants that influence virulence will highlight
new potential targets for antifungal therapy. Characterizing these variants will also pave the way for future inves-
tigations of the mechanistic basis of their effects, which will elucidate key features of cryptococcal biology and
pathogenesis. Our methods are applicable to other fundamental questions in cryptococcal biology, and poten-
tially to other microbial pathogens. Finally, our studies will produce valuable reagents and data sets that will
enhance investigations by other C. neoformans researchers.

Public health relevance
PROJECT NARRATIVE The pathogenic fungus Cryptococcus neoformans causes a meningoencephalitis that kills almost 200,000 peo- ple per year. Striking differences in virulence are observed among naturally occurring strains of this microbe. The goal of this research is to identify the regions of the genome, and specific changes in DNA sequence, that are responsible for these differences. Successful completion of these studies will establish powerful new meth- ods and significant community resources for research, increase fundamental understanding of this organism and the disease it causes, and potentially impact antifungal drug development.